Promoting Lead Academic Participating Sites (LAPS) Studies Accrual and Lung cancer Screening in Oklahoma

Abstract/Summary
Lung cancer mortality in Oklahoma is higher than the national average with age adjusted rate of
46.5 compared to 35 per 100,000 population. I am a thoracic medical oncologist with high
interest in clinical and translational research. I joined Stephenson Cancer Center of the
University of Oklahoma Health Sciences Center in 2014 with the goal of improving lung cancer
care in the state. In 2015, I joined the lung committee of SWOG Cancer Research Network, and
I have been an active member of that group since then. I regularly participate in monthly virtual
meetings and bi-annual in-person meetings of that group to explore and evaluate new ideas to
improve care of lung cancer patients. I worked with my colleagues in that committee to develop
a study to improve the care of stage 2 and 3 non-small cell lung cancer (NSCLC) patients with
borderline performance status. That study, SWOG 1933, is currently open to enrollment and I
am the national PI on it. I also, proposed a research concept to study perioperative versus
adjuvant chemo-immunotherapy in early-stage NSCLC and we submitted that study through
SWOG. I worked with my colleagues in the Alliance Cancer Research Network, and we jointly
received the first Clinical Trial Innovation Unit (CTIU) grant to run that study as CITU 2317. That
study would likely define the new standard of care in early-stage NSCLC. I joined the NRG
Oncology Research Network in 2019, and I have been an active member of the lung core
committee of that group since then and I regularly attend their meetings. I am also the medical
director of the clinical trial office in our institution and a local PI on phase one and later phase
thoracic oncology studies. The R50 Research Specialist Award will allow me to continue to be
an active member of the NCI cooperative groups, to develop innovative clinical trials to improve
lung cancer care in Oklahoma and mentor junior faculty and fellows in our institution in the field
of clinical and translational research.

Public health relevance
Narrative Clinical and translational research is the cornerstone of improving lung cancer care in Oklahoma, the United States and worldwide. Dr. Aljumaily is an active member of the NCI cooperative group system and the director of the thoracic oncology clinic and the medical director of the clinical trial office at the Stephenson Cancer Center of the University of Oklahoma. This R50 Award would help Dr. Aljumaily to continue to be an active member of the NCI cooperative group system, develop and optimize clinical trials, mentor junior faculty and fellows in our institution and ultimately improve the care of lung cancer patients in Oklahoma.